A New Device to measure Whole and Tissue Level Bone Strength.

Project Summary/Abstract
Most patients who fracture have non-osteoporotic bone mineral density. Often, the result of a
fracture is devastating and results in substantial morbidity and health care costs. One cause of
fragility in these patients is poor bone quality that subsequently contributes to higher risk for
fracture. Yet few techniques are available to accurately assess bone quality in the clinic. Dual
energy x-ray absorptiometry (DXA) is the most used clinical surrogate for fracture risk, but DXA
does not account for bone quality and thus overestimates bone health. OsteoProbe® enables the
measurement of bone quality in human patients and has been FDA cleared. The OsteoProbe®
quantifies bone material quality as a measure termed bone material strength index (BMSi) at the
tibia through a rapid microindentation process. A significant and highly predictive relationship has
been demonstrated between tibial BMSi and fracture occurrence at multiple skeletal sites. BMSi
has also been shown to be strongly predictive of bone strength at the femoral neck. The ongoing
SBIR Phase II study is investigating the relationship between OsteoProbe measurements at the
tibia and bone strength at these clinically relevant skeletal sites on post-menopausal cadavers.
We hypothesize that OsteoProbe® measurements will also prove valuable for HIV patients who
are at higher risk of fracture but do not have low BMD. The proposal aims to: (1) Contrast DEXA
and BMSi as predictors of true bone strength between HIV+ and HIV- populations across multiple
skeletal sites, and (2) Determine the microstructural and tissue-level changes in HIV bone that is
detectable by the OsteoProbe, compared with those of the normal aging population. We
hypothesize that HIV+ bones will exhibit impairments at lower length scales that differentially
affects BMSi than non-HIV bones.

Public health relevance
Narrative Patients who suffer a fracture but have non-osteoporotic BMD present a unique challenge to physicians since they have no way of identifying these patients before a fracture occurs. A new device for measuring living bone tissue quality, OsteoProbe, was developed as a result of private investment, research and development and its measurement, Bone Material Strength Index (BMSi) is predictive of skeletal fragility in fracture-susceptible populations. This administrative supplement is submitted in response to NOT-AG-22-014 and focused on improving the understanding and the diagnosis of secondary osteoporosis, and HIV-associated Comorbidities, Coinfections, and Complications (CCCs) recognized in the Key NIH HIV Research Areas.